Supportive Care Needs in Asian Americans with Metastatic Cancer

Project Summary
Cancer is the leading cause of death for Asian Americans, the fastest growing U.S. immigrant group projected
to outnumber Latinx Americans by 2065. Provision of high-quality supportive care for Asian American cancer
patients with metastatic disease is critically needed; however, there is a dearth of literature on this topic. Within
the Asian American population, Confucian-heritage East Asian and Southeast Asian ethnic groups share
cultural values and norms relevant to tailoring cancer care, and a goal of the K99 phase is to generate mixed-
methods data on supportive care needs specifically for Chinese-, Vietnamese-, and Korean-descent (CVK)
patients with metastatic cancer. Findings from the K99 phase will be shared with research participants and
applied collaboratively to develop culturally relevant supportive care resources in the R00 phase. The overall
training objective of this Early K99/R00 is to provide Dr. Kim with additional years of mentorship to become a
highly qualified independent investigator at the intersection of culture and supportive oncology. Training goals
include developing competencies in: 1) patient/family-centered and stakeholder-engaged cancer care
research, 2) patient-reported outcomes, needs, and preferences in metastatic cancer, 3) advanced mixed-
methods research particularly for working with non-English speaking participants, and 4) psychosocial
intervention development in cancer. Through the proposed training, Dr. Kim’s background in qualitative and
quantitative research, culturally-grounded research in Asian American populations, and cancer-related coping
processes will be integrated to solidify expertise in mixed methods and cultural implications for
psychosocial/behavioral cancer control as she transitions into an independent tenure-track faculty position.
During the K99 phase, Dr. Kim will be under the primary mentorship of Dr. Annette Stanton at UCLA, alongside
a strong co-mentorship team of experts (Drs. Marjorie Kagawa-Singer, Qian Lu, Anna Lau) committed to
advancing Dr. Kim’s career. The proposed research will also document participants’ reflections about the
experience of collaborative research for developing future guidelines on inclusive research practices that
promote advocacy. Dr. Kim’s long-term plan is to develop, test, and disseminate supportive care resources and
interventions that are culturally relevant and scalable, toward the ultimate goals of facilitating quality care and
improving outcomes in understudied populations with metastatic cancer.

Public health relevance
Project Narrative Cancer incidence is expected to increase to 23.6 million by 2030 worldwide, and cancer is the leading cause of death for Asian Americans whose numbers are rapidly rising to reach 40 million by 2050. Despite instances of greater cancer-specific mortality compared to other Asians and likely limited access to high-quality care due many experiencing language barriers (~50%), very little is known about supportive care needs in Chinese-, Vietnamese-, and Korean-Americans with metastatic cancers. This project will fill a critical gap in our understanding, and develop culturally relevant and scalable psychosocial resources aimed at improving the quality of life of Chinese-, Vietnamese-, and Korean-Americans with metastatic cancers.